Parametric design software for nanostructured CRISPR payloads

PROJECT SUMMARY
More than 300 million people worldwide are affected by a genetic health condition. Over 4,400 genetic
diseases have been identified; nearly all of which are considered rare, which limits the amount of research
each receives. Gene therapy is an attractive approach for treatment of genetic disease because of its broad
applicability. CRISPR-Cas9 genome editing systems (CRISPR) have revolutionized gene therapy research and
other fields of life science, however, no CRISPR-based treatments have reached the market and clinical
application still faces important challenges.
In this project, we aim to develop design automation software to help improve how genetic donor templates are
packaged for genomic integration via CRISPR, thereby increasing CRISPR editing efficiency. Whereas such
templates are usually delivered as unstructured (linear) single-stranded DNA, recent studies indicate genome
integration efficiency is significantly improved when templates are folded into compact shapes using
techniques from DNA nanotechnology. Such nanostructured genetic payloads (NGPs) for CRISPR have the
potential to become an essential component of genetic therapy and personalized medicine. The long-term goal
of the project is to provide researchers with software for designing more effective CRISPR treatments to
improve the lives of people with genetic health problems. Our solution will also advance other application
domains where DNA nanotechnology is being employed, such as nanomedicine, nanosensing and
biocompatible nanomaterials, thereby supporting the mission of the National Institute of General Medical
Sciences (NIGMS): improving the effectiveness of computational approaches in biomedical research.
Academic software exists to facilitate design of DNA nanostructures, however, these applications either require
extensive expertise or are limited to 3D wireframe designs. Design of a novel DNA nanostructure of modest
complexity that is not among a small set of simple designs can require hundreds of hours of expert labor.
Moreover, because NGPs are new to science, no software currently exists to automatically generate DNA
nanostructures for a given set of NGP design parameters. In Aim 1 of this project, we will employ an iterative
design-build-test development cycle we have used to bring other software products to market to develop novel
parametric design software (PDS) able to create NGPs automatically for a given genetic template and set of
design parameters. In Aim 2, we will simulate and synthesize eight NGPs and characterize them via molecular
modeling and atomic force microscopy to confirm they meet design specifications. We will then test these
NGPs for CRISPR editing efficiency against unstructured payload controls in vitro. In Phase II, we will enhance
the PDS and use it to explore the vast space of NGP designs for those that optimize CRISPR performance via
combinatorial testing across multiple cell lines, templates and insertion targets. Ultimately, we aim to
commercialize NGP software and design services to accelerate CRISPR research.

Public health relevance
PROJECT NARRATIVE A new method of editing the human genome called CRISPR has the potential to treat the hundreds of millions of people with a genetic health condition by allowing defective sequences in their DNA to be overwritten with DNA having corrected sequence. New evidence indicates this editing process is more efficient and less toxic if the corrected DNA is first stitched into a compact package using smaller DNA fragments. In this project, we will develop software that automatically determines the set of DNA fragments, which are unique to each editing situation, that are needed to create such compact packages for the purpose of devising improved genome editing therapies.